New Multi-Drug Resistance Mechanism in Multiple Myeloma

Multiple myeloma (MM) is the second most common hematologic malignancies and is currently considered
incurable with a 5-7 year median survival. Newer drugs, such as the proteasome inhibitors, immunomodulatory
drugs and monoclonal antibodies in combination with more traditional drugs enable better clinical responses.
However, development of resistance to these drugs is still the major cause of patient demise. There is also a
significant fraction of newly diagnosed MM patients who are refractory even to these newer drugs and thus have
not benefited from the recent therapeutic advancements. We previously found that many MM patient-derived
bone marrow mesenchymal stromal cells (BMSCs), a key MM tumor microenvironment cell type, secrete
factor(s) capable of activating transcription factor NF-κB and causing proteasome inhibitor resistance in MM
cells. We now identified HAPLN1 (hyaluronan and proteoglycan link protein 1) as a responsible BMSC secreted
factor that also causes such drug resistance in MM cells in vitro and in vivo. RNA-seq and bioinformatic analyses
revealed that HAPLN1 induces large-scale transcriptomic changes, including induction of a host of antiapoptotic
genes. Accordingly, HAPLN1 also causes resistance to multiple other drugs in MM cells in vitro. HAPLN1
expression is higher in MM BMSCs relative to normal BMSCs, and proteolytic forms of HAPLN1 are often
detected in bone marrow plasma from highly therapy refractory MM patients. Thus, we hypothesize that HAPLN1
is a new oncogenic factor and multi-drug resistance inducer in MM disease. This hypothesis will be tested by
determining the pathologic role of HAPLN1 in primary MM patient cells and in vivo (Aim 1), elucidating the
mechanism of HAPLN1-mediated drug resistance in MM (Aim 2), and immuno-targeting HAPLN1-mediated drug
resistance in MM (Aim 3). Overall, the proposed study may identify soluble HAPLN1 as a novel marker for
therapy resistance in MM, as well as a new therapeutic target to prevent or reduce the multi-drug resistance
problem in MM.

Public health relevance
Multiple myeloma is currently considered incurable due to the development of drug resistance disease that ultimately causes patient’s death. This study is expected to define a new mechanism and a factor for drug resistance in myeloma. It will also develop assays to analyze individual patients’ drug response as well as reagents to reduce drug resistance. Such assays may be used to determine which patients might harbor the specific resistance factor and therefore to select patients who might most benefit from a future therapy targeting the causative factor identified here.